Molecular characterization of ascites fluid to identify drivers of infection in patients with decompensated cirrhosis

Project Summary
In patients with liver cirrhosis, infection is directly responsible for 30-50% of all deaths. The most common
infection in patients with cirrhosis is spontaneous bacterial peritonitis (SBP), an infection that develops in
excess abdominal fluid, known as ascites fluid. SBP accounts for ~25% of infections in hospitalized patients
with cirrhosis, and results in a 4-fold increase in mortality. An improved understanding of the microbial and host
features in cirrhotic ascites that drive the susceptibility to SBP is central to improving outcomes. The objective
of this proposal is to apply a two-pronged, unbiased approach to develop a foundational metagenomic, meta-
transcriptomic, and serological atlas of ascites, to test the hypothesis that patients with cirrhosis have a
unique host and microbial signature that can identify those at greatest risk of SBP and mortality.
These objectives will be addressed in Aim 1 through the application of metagenomic next generation
sequencing (mNGS) and meta-transcriptomics to the study of ascites fluid, to determine whether these gene
signatures can predict poor outcomes in cirrhosis, specifically SBP and mortality. These objectives will be
further carried out in Aim 2 by employing a customized phage display library of peptides (representing a broad
array of intestinal bacteria) to identify the ascites antimicrobial antibody repertoire. These experiments will
establish a foundational dataset to determine the bacterial composition of ascites, parallel host response, and
impact on outcomes in patients with cirrhosis. Accomplishing these specific aims will yield a comprehensive
atlas of ascites microbial and serological composition, uncovering novel host and microbial attributes with the
potential to predict outcomes and inform interventions.
The candidate’s long-term career development goal is to be an independent physician scientist focused on
uncovering the mechanisms of increased infection risk in patients with cirrhosis. The proposed career
development plan will help the candidate master molecular and analytic approaches required to identify
mechanisms of disease directly in patients with cirrhosis, and develop into an intendent scientist, generating
results that can be used to develop tailored prevention strategies, improved diagnostics, and targeted
therapeutics.

Public health relevance
Project Narrative In patients with liver cirrhosis, infection is directly responsible for 30-50% of all deaths, the most common infection being spontaneous bacterial peritonitis (SBP) – a life-threatening, difficult to detect infection that develops in excess abdominal fluid, known as ascites fluid. An improved understanding of the microbial and host features in cirrhotic ascites that drive the susceptibility to SBP is central to improving outcomes. This work applies novel methods with the potential to uncover unidentified host and microbial attributes with the potential to predict outcomes in cirrhosis, and inform new treatments and interventions.